Light-Driven Deracemization of Atropisomers Enabled by Chiral Photocatalysts

PROJECT SUMMARY
Small-molecule medicines have saved countless lives, but a plethora of proteins remain “undruggable”
because of the molecular complexity needed to interrupt disease-causing processes. Generally, small-molecule
drugs operate by intimate binding to a target protein; maximizing specific drug/protein interactions enables high
potency and minimizes off-target effects. One promising strategy to improve drug binding is to incorporate
structural rigidity by an atropisomeric axis, wherein restricted bond rotation leads to distinct chiral atropisomers.
However, current methods to access atropisomers, including asymmetric couplings and chiral separations, lack
generality and efficiency. In contrast, deracemization of racemates, which are readily formed by cross-couplings,
represents an attractive approach to access atropisomers. Recent efforts have enabled deracemization of
atropisomers by combining racemization catalysts with chiral separations, but these approaches require chiral
reagents that limit applicability; deracemization without stoichiometric additives is challenging because the
transformation is thermodynamically unfavorable. The proposed research focuses on the development of a
broadly applicable strategy to deracemize atropisomers by light-driven processes that utilize excited-state energy
surfaces to achieve this net-uphill reaction. The impact of this work is to enable facile access to atropisomers
from readily available racemates, making possible the design and rapid synthesis of new drug candidates. In
contrast to prior approaches for catalytic deracemization of engineered substrates that rely on pendant binding
sites which mitigate generality, the innovation of the proposed approach is a set of readily accessible
photocatalysts designed to bind the native functionality in atropisomers and to react by different activation
pathways tailored to these different groups. Specifically, the proposed research will create new photocatalyst
scaffolds that will enantioselectively bind two distinct classes of atropisomers, biaryls and anilides, and enable
stereoselective photoinduced energy or electron transfer to facilitate deracemization. Modular synthetic routes
are presented to access two libraries of catalysts that span a wide range of photophysical properties, chiral
environments, and binding elements that will be iteratively combined to optimize for substrate binding. For each
distinct class of atropisomers, subsequent excited-state quenching experiments will be conducted to evaluate
catalysts for their ability to discriminate between substrate enantiomers and facilitate enantioselective energy or
electron transfer. Catalysts that exhibit the most disparate ground-state binding affinities and excited-state
quenching kinetics will be applied for deracemization of atropisomers, and studies of the deracemization of
complex structures, particularly those found in pharmaceutically relevant molecules, will demonstrate the
applicability and generality of the proposed method. Achieving the specific aims of the proposed research will
enable practical, general access to enantiopure atropisomers, expand access to new chiral frameworks for drug
discovery and ultimately leading to improvements of disease-treating therapeutics.

Public health relevance
PROJECT NARRATIVE The development of new disease-treating compounds that possess high potency and low toxicity requires synthetic strategies to rapidly create rigid molecular scaffolds that fix the position of substituents in space to selectively target complex proteins. This proposal comprises an approach to access to conformationally rigid atropisomers found in medicinally relevant molecules by leveraging the native functional groups found in these motifs to facilitate deracemization of readily generated racemates. Employing two classes of newly designed chiral photocatalysts, deracemization of numerous atropisomers can be achieved by enantioselective electron or energy transfer to selectively convert one enantiomer into the other.